PRE3BAD: Preclinical Research on Emerging Environmental Exposures, Brain Aging, and Dementia

Environmental stressors may promote and/or accelerate neurodegenerative diseases. The US population has
been progressively aging, resulting in prolonged duration of environmental toxicant exposures and a potential
for increased vulnerability to new environmental insults. Consequently, there is a growing population at risk for
Alzheimer’s disease (AD) and AD-related dementias (ADRDs). Our appreciation of the effect of various
pollutants, including wildfire smoke, microplastics, and heavy metals, on neurological conditions is still
evolving. Compelling new evidence shows that PM, and specifically wood smoke, can induce
neuroinflammation and blood-brain barrier (BBB) deficits and also alter the brain metabolic profile and
contribute to behavioral impairment, the effects of which are more persistent in advanced aging. While limited
research exists on microplastics and neurological outcomes, we have shown that orally delivered microplastics
can accumulate in the brain and promote metabolomic changes, while another study suggests that micro- and
nano-plastics may cross the BBB and induce mis-folding of proteins relevant to amyloidosis. Lastly, numerous
transition and heavy metals in our diet have been associated with neurodegenerative outcomes, including
manganese, cadmium, lead, and copper. We propose that early-life exposures are largely recoverable
compared to later-life exposures and, furthermore, that intermittency of exposures circumvents adaptation
mechanisms and promotes a sustained negative impact on ADRD-related phenotypes. In aim 1, we will assess
the neuropathological impacts of emerging environmental contaminants across disparate temporal patterns in
complementary mouse models of AD/ADRD. Using established regimens of a) wildfire smoke, b) microplastics,
and c) mixed heavy metals, we will expose WT (C57BL/6J) and AppNL-F
and
MAPT KI mouse model of
amyloidosis and tauopathy to contrast ADRD resistant and vulnerable phenotypes. Exposure designs will
include i) early life, ii) late-life, iii) intermittent, and iv) continuous lifespan exposures. Thorough molecular and
histopathological assessment will be conducted at 18- and 24-mo of age to reflect early and late stages of
AD/ADRD pathogenesis. In aim 2, we will comprehensively delineate multi-omic pathways perturbed by
environmental exposures that augment AD/ADRD outcomes. Multi-omic characterization will include
metabolomic, lipidomic, proteomic, transcriptomic, high-dimensional flow cytometry, and epigenetic
assessments, with computational integration to identify key pathway perturbations. We identify those pathways
activated or inhibited by environmental exposures and further refine the assessments to ascertain novel
environmentally perturbed pathways that exacerbate AD/ADRD phenotypes and may help resolve uncertainty
in AD/ADRD risk prediction. This comprehensive preclinical program brings together major scientific resources
from the University of New Mexico’s Brain and Behavioral Health Institute and the Center for Metals in Biology
and Medicine, along with key collaborations from Arizona State and Texas Tech Universities.

Public health relevance
The US population has been progressively aging, resulting in prolonged duration of environmental toxicant exposures and a potential for increased vulnerability to new environmental insults. Consequently, there is a growing population at risk for Alzheimer’s disease and related dementias. This project will examine the effect of various pollutants, including wildfire smoke, microplastics, and heavy metals, on neurological conditions and multi-omic pathways leading to neurodegenerative disease.